RCMI@Morgan: Center for Urban Health Disparities Research and Innovation

Administrative Core – Summary
The goal of the proposed RCMI Center for Urban Health Disparities Research and Innovation
at Morgan State University (MSU) (RCMI@Morgan) is to enhance the infrastructure and
capacity needed for MSU to become a significant player in conducting health disparities
research of urban significance in areas such as infectious diseases (including sexually
transmitted diseases), cancers and diabetes, addiction and abuse prevention, social
determinants of health, food security and health informatics. This research will encompass both
basic biomedical science and behavioral/public health sciences. The main goal of the
Administrative Core is to provide leadership and oversight, administrative and logistical support,
fiscal and budgetary management, effective communications and provision of information
regarding career enhancement workshops and activities to postdoctoral fellows and junior
faculty, program evaluation, and project reports. It will also facilitate collaborations with partner
research institutions through the Research Infrastructure and Investigator Development Cores,
as well as government agencies and communities by working closely with the Community
Engagement Core.